Coordination Section

2. ABSTRACT - Coordination Section
The BCM Center for Precision Medicine Models (CPMM) supports local, national, and international programs
and individual researchers in the development of precision animal models that (1) end the diagnostic odyssey of
patients with undiagnosed, rare, and Mendelian diseases and (2) serve as resources for pre-clinical studies
investigating personalized medicine approaches to their care. The Coordination Section will provide
multidisciplinary scientific leadership for the CPMM. This Section will leverage the multi-PI (Heaney, Burrage,
Yamamoto, and Milosavljevic) and Program Manager (Lanza) group’s established experience leading large
research programs, such as CPMM, and expertise in clinical and molecular genetics (Burrage), model organism
production and phenotyping (Heaney, Yamamoto), and human and model organism bioinformatics
(Milosavljevic) to coordinate all administrative and scientific activities of the Center. The Coordination Center
employs a steering committee and organizational structure to supervise the workflow among the Center Sections
and Units and oversee day-to-day operations of the various components of the Center. The Coordination Section
will continue to be responsible for maintaining internal and external Center communications by scheduling
meetings of section/unit working groups, all center staff, and the Center Steering Committee. These meetings
will be used to review section/unit operations, track project and milestone progress, and select submitted variants
for modeling. To ensure efficient Center operations, project progression, and data reporting, the Section will also
maintain, review, and update all established Center policies and standard operating procedures. In collaboration
with the other Sections, the Coordination Section will continue to implement strategies for outreach and
recruitment of local, regional, and national community-based submissions for variant modeling. The Coordination
Section will also establish an External Advisory Board (EAB), schedule EAB meetings, and implement corrective
measures identified by the EAB after each annual meeting. Finally, the Coordination section will monitor Center
performance and impact on biomedical research.